Centering Patients: Development of a Tailored eHealth Intervention to Improve the UF Patient Experience

Modified Project Summary/Abstract Section

Project 3, entitled “Centering Patients: Development of a Tailored eHealth Intervention to Improve the UF Patient Experience”, focuses on understanding the drivers of differences in UF care and developing an individually-tailored intervention to improve patient experiences. As with the overall Center, this project will be guided by the principles of Community-Based Participatory Research under the direction of our Community and Stakeholder Advisory Board. Our preliminary data from Black patients with UF indicate that they are often dissatisfied with both their own understanding of UF as well as the care they receive. They want to be at the center of their care. Interventions are needed that support patient autonomy and move toward a more patient-centered care model. The overall objective of Project 3 is to conduct formative work to understand the knowledge, attitudes, norms, beliefs, emotions, and lived experiences of Black women with UF and use these insights to develop an individually-tailored digital tool to optimize UF care for future implementation and testing. The digital tool will also convey key patient-reported information to providers to ensure that they are aware of patient knowledge gaps, emotions, treatment preferences, and reproductive plans. To achieve this, we propose three Aims:1)Quantitatively explore knowledge, attitudes, beliefs, and behaviors around uterine fibroids as well as reproductive health more broadly amongst U.S. Black and White women;2)Qualitatively explore experiences of UF patients and providers; and3)Develop an individually-tailored, interactive eHealth intervention to increase knowledge, mitigate barriers, improve self-efficacy, and facilitate optimal patient-provider communication. Project 3willdevelop a culturally-tailored, personalized intervention that we believe will decrease differences in the fibroid patient experience that significantly and negatively impact Black women. However, once created, the individually personalized tool will improve the uterine fibroid patient experience generally-positively impacting all women.